Development Research Project Program

An important component of the WV-INBRE program is the Developmental Research Project
Program. The goals of the Developmental Research Project Program are to strengthen the
biomedical research capacity and competiveness of network investigators and provide research
opportunities and skills development for network students. To accomplish these goals, the
Developmental Research Project Program will offer both Research and Pilot Project awards for
which only primarily undergraduate institution (PUI) faculty are eligible. These programs include
the Research Project program, Major PUI Research Awards, and four Pilot Project Award
mechanisms (Faculty Research Development Awards [FRDAs], Center for Natural Products
Research (CNPR) Pilot Awards, Chronic Disease Pilot Awards and Collaborative Program
Awards, which are new for Phase V). Major PUI Research Awards are up to two-year awards for
up to $125,000/year and are designed to help move investigators toward independent status. A
maximum of three awards in any year will be active. The remainder of the developmental awards,
with the exception of WV-INBRE PUI Collaborative Awards, provide a maximum of $50,000/year
and are one-year awards. The Collaborative Awards with two WV-INBRE Investigators from
different PUI institutions working together on a pilot project, can request up to $30,000 per PI for
a maximum of $60,000. Collaborative program grants will also fund WV-INBE researchers
collaborating with Puerto Rico INBRE investigators through the CNPR program. This is a new.
The FRDAs target PUI investigators that need more experience or preliminary data to compete
for major awards and support one-year projects. These investigators are often new PUI faculty.
Center for Natural Products Research Pilot Grants support one-year projects, which study natural
products in the arena of cancer or infectious disease chemotherapy. WV-INBRE researchers also
have the opportunity to interact with the National Center for Natural Products Research at the
University of Mississippi to obtain extracts and pure compounds for study. Chronic Disease
Research Program pilot grants are for one-year and provide funding for PUI investigators to study
all aspects of the many chronic diseases that West Virginians experience. With the scientific
emphasis of WV-INBRE on chronic diseases, this program is particularly appropriate.

Public health relevance
The Development Research Project Program will provide research funding to PUI network investigators to conduct biomedical research projects with a focus on chronic diseases an provide opportunities for student training in biomedical research. Included in these programs are pilot project programs that focus on natural products research in chemotherapy, including a new collaborative initiative with investigators in the Puerto Rico INBRE.